INTRAVENOUS GAMMA GLOBULIN IN HIV INFECTED CHILDREN RECEIVING ZIDOVUDINE

This study is designed to determine if there is benefit from treating HIV positive children receiving Zidovudine with intravenous gammaglobulin.